Cannabis use, trauma, and self-regulatory cognitive processes: A multimodal study integrating biobehavioral markers and ecological assessment

PROJECT SUMMARY/ABSTRACT
Cannabis use (CU) to manage mental health symptoms is increasing in both clinical and recreational contexts,
particularly among young adults. This emerging trend reflects evolving attitudes surrounding cannabis and
underlines a need to evaluate the physical, psychological, and sociocultural factors involved. The present
study examines how cognitive processes related to decision-making (i.e., reward motivation and inhibitory
control) relate to CU during emerging adulthood (age 18-25) – a crucial developmental period – following a
potentially traumatic event. We hypothesize that disruptions to these decisional processes post-trauma drive
alterations to CU that result in a mutually reinforcing behavioral pattern whereby pleasurable sensations from
CU in the short-term result in lowered hedonic tone overall and long-term adverse cannabis-related outcomes
(i.e., cannabis use disorder, greater frequency/quantity of use, cannabis-related problems). The present study
leverages methodological advantages of the parent study (R01DA054116; e.g., psychophysiological
measurement, ecological momentary assessment, wearable biosensors, longitudinal follow-ups) and
implements additional objective measures of cognitive processes related to discrete choice behavior.
Specifically, the present project will recruit 70 participants from the parent project, add two baseline self-report
measures of hedonic tone and impulsivity, and add two behavioral tasks assessing reward motivation and
inhibitory control at two study timepoints – 2-weeks post-trauma and 6-months post-trauma. The present study
will use sequential sampling modeling (SSM), which unites trial-level data from behavioral tasks with
physiological data to derive inferences into latent decision-making processes that cannot be inferred by group
averages. We will develop computational models of these behavioral tasks using SSM and integrate
parameters derived from them into intensive longitudinal analyses to evaluate cognitive mechanisms
underlying the relationship between psychobiological trauma reactivity and CU. Specifically, we will assess
relationships between traumatic stress reactivity, reward motivation, and inhibitory control (Aim 1); detect how
decisional processes and CU are affected by fluctuations in psychophysiology and hedonic tone (Aim 2); and
evaluate psychophysiological and behavioral markers of the developmental trajectories of problematic CU
following trauma (Aim 3). Through this National Research Service Award, the PI will further develop and refine
his program of research to integrate naturalistic behavioral and physiological observations with advanced
quantitative modeling which will lead to both crucial scientific insights in the short-term and set the stage for
future studies. This project will be conducted within an individualized training program to facilitate the
acquisition of key skills and knowledge progress toward career goals. This includes advanced didactic and
experiential training in (1) EMA methodology, (2) behavioral task implementation, (3) computational modeling,
(4) advanced analysis of intensive longitudinal data, and (5) grantsmanship and manuscript preparation.

Public health relevance
PROJECT NARRATIVE Although cannabis use for both therapeutic and recreational treatment of mental health concerns is increasing, especially among emerging adults, a research gap assessing the cognitive and psychobiological mechanisms underlying cannabis use behaviors following a traumatic event remains. Two important cognitive processes involved in cannabis use decision-making are inhibitory control and reward motivation. The proposed project utilizes a multi-modal approach (i.e., psychophysiology, behavioral tasks, ecological momentary assessment, computational modeling) to identify and isolate idiographic profiles of these decisional processes and develop longitudinal models of posttraumatic stress and cannabis use behavior in emerging adults.